Bionic and robotic prostheses: identifying bioethical concerns from key groups to improve development and clinical translation approaches

ABSTRACT
Rates of amputation are expected to double by 2050, and prosthesis use is expected to increase accordingly.
As prosthetic technology continues to advance, bioethical concerns surrounding the development and clinical
translation of bionic and robotic prostheses persist. Specific concerns include a lack of incorporating user needs
and feedback, insurance reimbursements, equitable research participation and device access, as well as the
increased use of data monitoring. These bioethical concerns are relevant for prostheses with and without robotic
technology. However, these concerns may be magnified in bionic and robotic prostheses due to the addition of
higher costs associated with advanced technology, as well as additional concerns specific to advances in
technology. Substantial funding, particularly from the National Institutes of Health, has been allocated to develop
bionic and robotic prostheses and translate devices into clinical practice. However, bioethical considerations and
barriers to development and translation remain undiscussed, contributing to a widening gap between research
and clinical practice. No studies have reported bioethical issues related to bionic or robotic prostheses from the
perspectives of people with limb loss and difference, clinicians, or policy makers. Perspectives from these groups
are critical to help establish policy guidelines, reduce wasted research costs, and ensure these devices can
actually improve patient quality of life. Therefore, our objective is to disseminate bioethical concerns among
people with limb loss and limb difference (both upper-limb and lower-limb), clinicians, and policy makers to
improve approaches in the development and translation of bionic and robotic prostheses. We will recruit these
key groups across the US to: 1) determine bioethical concerns from their perspectives, and 2) include these
concerns in a brief, decisional support document to help researchers, manufacturers, and funders improve their
approaches to development and clinical translation. In alignment with several priority areas of this RFA, we will
explore perceptions on topics such as equitable distribution of device access and follow-up care, research
participation, and device use. We will target people from underserved communities (e.g., systematically
marginalized groups, rural communities) and those who have been traditionally underrepresented in prosthetics
technology research (e.g., older adults, dysvascular etiologies) for recruitment to ensure perspectives from this
population are included. Participants will complete semi-structured interviews, with interview questions based on
the Johns Hopkins conceptual framework for ethics in a learning healthcare system. Descriptive statistics and
systematic thematic analysis will be used to help identify key groups’ high priority and prevalent bioethical
concerns, which will be summarized in our decisional support document to highlight considerations for
researchers, manufacturers, and funders. Findings will be crucial to help inform research and policy decisions,
which may positively affect the quality of life for people who can benefit from bionic and robotic prostheses.

Public health relevance
PROJECT NARRATIVE Bionic and robotic prostheses have garnered a large amount of funding and media attention over the last decade, but bioethical concerns that have impeded development (e.g. incorporating user needs and feedback) and clinical translation (e.g., reimbursement, device access) remain overlooked. These development and clinical translation concerns have contributed to poor patient outcomes and access to care, as well as wasted research costs. Identifying bioethical concerns from the perspectives of people with limb loss and difference, clinicians, and policy makers can help guide future development and clinical translation approaches, which are crucial for ensuring bionic and robotic devices improve the quality of life of people who use a prosthesis.